BIOMEDICAL DATA TRANSLATOR USER INTERFACE DEVELOPMENT

As the pace of scientific research continues to advance, the problem researchers face now is not a lack of information, but pairing the right data with the right question. The vision of Biomedical Data Translator is to help researchers more easily see connections across those data, accelerating discovery and getting more treatments to more patients more quickly. Ultimately, the Biomedical Data Translator will accomplish this by serving as a resource for computationally-assisted exploration of knowledge and construction of new research hypotheses. As the Translator program enters the Development phase, the design of the interface is critical/imminent to ensure that the development of the core system supports the needs of the users. The awardees of the Biomedical Data Translator: Development funding opportunity are continuing to develop integrated tools that connect diverse types of data to augment human reasoning and inference for understanding the pathophysiology of human disease. Individual teams have subject-matter experts that utilize components or tools to validate findings, however there is no user interface for Translator. Through the User Experience (UX) Lifecycle contract, the program will develop an interface concurrently with the consortium developing the core system. The objective is to develop a user interface that facilitates biomedical researchers interactively exploring the Biomedical Data Translator resources and constructing new research hypotheses while ensuring that the emerging standards and development of the Biomedical Data Translator component tools support user needs.